Biological Embedding of Childhood Obesity: Stress Responsive Systems and Sleep

PROJECT SUMMARY/ABSTRACT
About a fifth of U.S. children are obese. Pediatric obesity has significant long-term ramifications for adult
health. Despite federal initiatives targeting physical activity and nutrition, rates of pediatric obesity have not
significantly decreased in the last two decades. This warrants increased attention to factors instantiating risk
for later obesity. Few studies examining stress biology and child obesity utilize longitudinal designs, objective
measures of stress, or integrate across multiple biological systems despite increasing acknowledgement of
their complicated interplay. The current proposal seeks to address gaps in the literature by integrating several
biological and developmental systems during early childhood into a predictive model for later overweight/
obesity. Biological systems of interest include the Sympathetic Adrenal-Medullary (SAM) System, which quickly
triggers physiologic and behavioral reactions to stressors, and Hypothalamic-Pituitary-Adrenal (HPA) Axis, a
hormonal response system reacting to longer-term stressors. This study utilizes collected data (RC1DK086376
PI: Lumeng/Miller) to examine: (1) pathways between SAM system and HPA Axis functioning during a
standardized stress task in toddlers and body-mass index (BMI) in middle childhood, (2) bi-directional
longitudinal associations between behavioral sleep quality and BMI across preschool to middle childhood, and
(3) the moderating role of behavioral sleep quality in longitudinal relationships between SAM system and HPA
axis stress reactivity in preschool and BMI in middle childhood. Children provided saliva samples throughout a
standardized stress task, from which cortisol (primary output of the HPA axis) and alpha amylase (indicating
SAM system activity) were assayed. Results will elucidate early biological embedding of risk for overweight/
obesity and can inform concurrent type and timing of effective interventions. An extensive training plan has
been designed alongside the current study to equip the applicant with skills needed for an independent
research career as a clinical scientist. Fellowship training goals are to: (1) Refine distinct research interests
and position for a clinical scientist career leading to an impactful research program, (2) Learn skills needed to
independently run a lab, (3) Hone skills in statistical modeling suited for longitudinal, multi-dimensional data
representing several biological systems, (4) Build productive, bi-directional community partnerships and skills
in disseminating research, and (5) Develop grant-writing skills. The applicant has assembled a dedicated, inter-
disciplinary team of scientists with relevant expertise in sleep, stress biology, obesogenic pathways, family
contextual factors, and community-academic partnerships. Training activities will primarily occur in the Depart-
ment of Psychology, University of Denver, where faculty conduct interdisciplinary, developmental psycho-
biology research using a variety of methodologies (e.g., fMRI, inflammatory markers). This training grant will
catalyze an independent research program investigating critical intersections of sleep, stress, and child health.

Public health relevance
PROJECT NARRATIVE Although obesity in childhood negatively affects long-term health, little research details ways that early functioning of biological systems can lead to risk for pediatric obesity; this gap limits effective programming. The current proposal tests coordination across two stress responsive systems, the Hypothalamic-Pituitary- Adrenal (HPA) axis and Sympathetic-Adrenal-Medullary (SAM) system, and sleep in early childhood as possible indicators for later obesity risk. Investigating how multiple biological systems interact with one another in early childhood to predict later obesity will critically inform prevention, treatment, and assessment of risk for obesity in childhood.